EFFECTS OF SYMPATHETIC AND PARASYMPATHETIC STIMULATION OF HEART RATE

The aim of this protocol is to evaluate the effects of sympathetic and parasympathetic stimulation on heart rate variability. Specifically, parasympathetic stimulation is accomplished with phenylephrine infusion which leads to a baroreflex mediated increase in parasympathetic tone. Sympathetic stimulation is performed with upright tilt and isoproterenol infusion.